Utilizing CRISPRa engineered stem cells for regeneration of the temporomandibular joint

Patients with Temporomandibular joint osteoarthritis (TMJ-OA) present with articular mandibular surface
degeneration, that when severe, leaves patients with no regenerative treatment options available and total joint
arthroplasty as the only surgical option when they can no longer function. Towards regeneration of the surface
of the TMJ condyle, we developed the goat as a large animal model to test tissue engineering strategies for the
TMJ. Our previous approaches have shown robust matrix deposition; however, bone was not observed to
regenerate and cartilage-bone interface was irregular and not organized. Thus, we have decided to explore
cell-based approaches to better control the architecture of the cartilage and bone layers. To this end, we will
employ synthetic biology approaches to guide progenitor cell differentiation into both chondrocytes and
osteoblasts, and then create bi-layer constructs with both cell types.
Clustered Regularly Interspaced Short Palindromic Repeats (CRISPR) epigenome modifications
facilitate targeted, multiplex, long-term regulation of endogenous gene expression without altering the base
pairs of the target genes. CRISPR based upregulation of collagen2 (COL2A1) combined with aggrecan
(ACAN), and CRISPRi based downregulation of noggin (NOG) in human adipose stem cells (hASCs) has been
demonstrated to promote chondrogenic or osteogenic phenotypes, respectively. In addition, Sox9 and Runx2
are known regulators of chondrogenic and osteogenic differentiation. We hypothesize that we can combine
these technologies into a bilayer hydrogel comprised of 1) a top layer consisting of gelatin hydrogel seeded
with Sox9/COL2A1/ACAN epigenome edited BMSCs and 2) a bottom layer consisting of a gelatin hydrogel
seeded with Runx2/NOG epigenome edited BMSCs that will better regenerate the cartilage-bone interface of
the mandibular condyle compared to hydrogel seeded with non-target edited BMSCs.
To test this hypothesis, we propose the following specific aims. In Aim1, we will demonstrate the ability
of Sox9/COL2A1/ACAN epigenome edited BMSC seeded hydrogels to form cartilage tissue in vitro. In Aim2,
we will establish the ability of Runx2/NOG epigenome edited BMSC seeded hydrogels to form mineralized
tissue in vitro. In Aim3, we will develop a bilayer hydrogel, composed of a Sox9/COL2A1/ACAN edited BMSC
layer and a Runx2/NOG edited BMSC layer, to form a cartilage-bone tissue interface in vitro. Finally, we will
test the ability of the Sox9/COL2A1/ACAN and Runx2/NOG edited BMSC seeded bilayer hydrogels to
regenerate the surface of the TMJ condyle in our goat large animal model of TMJ-OA. Overall, these results
will demonstrate the ability of CRISPR epigenome editing Sox9/COL2A1/ACAN and Runx2/NOG expression in
BMSCs to drive chondrogenic and osteogenic differentiation, respectively, and establish the use of CRISPR
epigenome edited BMSC based therapeutics as a potential treatment strategy for regeneration of the surface
of the TMJ condyle.

Public health relevance
The temporomandibular joint (TMJ) is prone to osteoarthritis (TMJ-OA) and it has been shown that one third of patients undergoing total replacement of the TMJ had TMJ-OA without comorbid conditions. Currently, no regenerative therapies to help patients with mandibular condylar cartilage pathology exist and the only surgical treatment option is end-stage arthroplasty with a total joint prosthetic. In this proposal, we develop a novel tissue engineering based therapeutic strategy for regeneration of the TMJ.